Chemical genetics of M. tuberculosis DosRST signaling and persistence

Mycobacterium tuberculosis (Mtb) is the leading cause of death by an infectious disease — 1.5 million
deaths and 10 million new active TB cases each year. A major reason the situation is not improving is that TB
treatment is lengthy and challenging, requiring 6 months or more of multiple antibiotics with serious side
effects. This regimen causes widespread non-compliance leading to relapse and promoting the evolution of
multidrug-resistant TB (MDR-TB).
Mtb is remarkably successful, in part, due to its ability to become dormant in response to host immune
pressures. Mtb has a two-component regulatory system (TCS), DosRST, that when induced by hypoxia, nitric
oxide (NO) or carbon monoxide (CO) remodels Mtb physiology to promote non-replicating persistence (NRP).
NRP bacteria are thought to drive the long course of TB treatment. Therefore, we hypothesize that inhibitors of
DosRST-dependent adaptation will reduce survival of drug-tolerant NRP Mtb and could function to shorten the
course of therapy. By an innovative, reporter-based whole-cell phenotypic screen of a >540,000 compound
library, we have discovered four new inhibitors that inhibit DosRST signaling by directly targeting the DosS and
DosT sensor kinases. These first-in-class chemical probes, HC101, HC102, HC103 and HC106, represent a
new strategy to inhibit Mtb persistence. Under hypoxia, all four compounds inhibit Mtb NRP-associated
physiologies, including triacylglycerol synthesis and survival. Mechanism of action studies show they directly
inhibit DosS and DosT kinases, but by distinct mechanisms; HC101 and HC106 directly target a heme group
embedded in the kinases, while HC102 and HC103 inhibit sensor kinase autophosphorylation.
A critical barrier to studying TCS is the lack of chemical probes that function against bacteria in whole cells.
The goal of this proposal is to use these chemical probes as new tools to dissect the biochemical mechanisms
of DosS/T sensor kinase function and the impact of conditional sensor kinase inhibition on Mtb physiology. Aim
1 will use biochemical and structure-activity relationship (SAR) studies to define mechanisms of action of the
probes. In Aim 2, genetic approaches will be used to identify amino acid residues associated with resistance to
the compounds and required for kinase function. Aim 3 will use CRISPR interference (CRISPRi), combined
with treatment with the chemical probes, to define the biological impact of conditional DosRST inhibition both in
vitro and during infection. This R01 will define new mechanisms for TCS function and generate proof-of-
concept data validating DosRST as a target for the development of new TB drugs.
OVERALL IMPACT: These studies will surmount obstacles that have long stymied TB therapy by focusing
small molecule development on new targets and bringing critically needed understanding of TCS function in
vitro and during infection.

Public health relevance
The spread of tuberculosis is a global health crisis leading to over one million deaths annually. The global burden of tuberculosis is a threat to the health of all Americans, and directly relevant to the mission of the National Institute of Allergy and Infectious Diseases, given the easy transmission of the disease through the air and the emergence of drug resistant strains that are difficult to treat. Moreover, there exists an increasing population of Americans with enhanced susceptibility to TB due to factors associated with compromised immune systems, including: HIV infection, the use of anti-rejection and anti-inflammatory drugs, as well as natural decreases in immunity associated with an aging population.